Femto-seq: Targeted photo-biotinylation, pulldown and sequencing of locus and region-specific DNA from femtoliter volumes within individual cells

Changes in the spatial organization of the genome are directly involved in gene regulation during differentiation,
cellular stress responses and disease initiation. Existing approaches such as chromosome conformation capture
(3C) methods and DNA fluorescent in situ hybridization (DNA-FISH) have provided information on the overall 3D
structure of the nucleus at the chromatin level, providing critical insights into how our genomes are regulated.
Nonetheless, new technologies are needed to uncover the finer details on the role of nuclear architecture,
topological domains, and genomic interactions. Studies of gene regulation would benefit from a technology that
fills the niche between the ensemble averaged 3C methods and the single cell, low throughput DNA-FISH
approach. We have recently developed a novel optical technology we call “Femto-seq” that does just this – it
allows users to obtain DNA sequence information from targeted femtoliter volumes within the nucleus of selected
cells. Femto-seq provides a new way to examine genomic contacts near a specific gene locus or any nuclear
region of interest (e.g. nuclear bodies). Using 3D localized two-photon excitation, we can photochemically
biotinylate any region of the nucleus we can fluorescently label and identify in volumes which can be as small as
a ½ of a femtoliter. The process is carried out on a population of cells using a combined two-photon/confocal
microscope which images, locates fluorescently labeled regions of interest and then irradiates those regions
using 700 nm femtosecond pulses to biotinylate the chromatin by photochemically cross-linking the DNA with a
psoralen-biotin compound. Nuclei are isolated and the biotinylated DNA from the targeted region pulled down
and sequenced. Because the cells are imaged to locate the regions of interest, they can also be screened for
other parameters, allowing for the collection of targeted biotinylated DNA only from user selected cells within the
cell population, providing single-cell like genomic information from a sub-set of cells within the population. We
have proof-of-concept data from a cell line with a fluorescently labeled transgene we used as our targeted region,
and show that we can obtain DNA highly enriched in transgene locus sequences. The goals of this Focused
Technology Research and Development R01 project are to (Aim 1) design and construct a dual confocal/two-
photon microscope capable of targeting and irradiating user selected regions-of-interest in a population of cells
in a high-throughput automated fashion, (Aim 2) create a chromatin isolation pipeline based on novel microfluidic
designs to efficiently purify and prepare the DNA for sequencing, and (Aim 3) demonstrate the improvement
obtained from aims 1 and 2 in a series of Femto-seq experiments designed to produce quantitative metrics of
improvement and to uncover new knowledge on how environmental signals may be relayed through the cytosol
and into the nucleus. Femto-seq is a unique new way of investigating the spatial and regulatory relationships
between DNA sequences and any microscopically visible region-of-interest in the nucleus.

Public health relevance
Narrative. The goal of this project is to develop a new image-correlated genomic technology that will improve the detection and characterization of genetic disease susceptibility, response to environmental factors, and help develop potential treatment regimens that arise based on knowledge gained from use of the technology. The method combines high resolution optical microscopy with DNA sequencing to allow researchers to obtain specific DNA sequence information from targeted nuclear regions in user-selected cells in the population under study. The technology will offer new insights into how genes are regulated by the environment and how the cell’s nucleus structurally reconfigures itself in response.